Systems biology of acute and chronic multi-organ failure in children with congenital heart disease

PROJECT SUMMARY
Approximately 25% of children with congenital heart disease (CHD) require intervention in the first year of life.
Although surgical mortality has decreased, the incidence of acute and chronic postoperative morbidities remains
high. Morbidities are primary drivers of hospitalization, long-term outcomes, and cost, and are most common in
children requiring neonatal surgery and those undergoing staged palliation for single ventricle heart disease
(SVHD). While our patients struggle with these morbidities daily, our understanding of the mechanisms and
molecular phenotypes of organ injury/recovery remain limited. Our preliminary data suggest that targeting a
limited number of biomarkers/pathways is insufficient to address the complicated reality of CHD. Instead,
diagnostic approaches allowing simultaneous measurement of hundreds of molecules (“omics”) paired with high
dimension data analysis techniques could represent a better strategy. Our team has been highly productive in
detailing the acute metabolomic and proteomic response to CHD surgery. We also found that the robust datasets
generated through this work provide an excellent environment for training junior researchers in data science
methods. Under this K24 proposal, we will use our two established cohorts (neonatal surgery and longitudinal
SVHD palliation) to expand beyond the acute postoperative period, exploring the systems biology of subacute
and chronic morbidity in our CHD patients. We will also leverage these high dimension datasets to train the next
generation of researchers interested in using data science techniques to improve the lives of children with CHD.
Overall Hypothesis: Postoperative injury and abnormal development following CHD surgery result in disruption
of the circulating proteome and metabolome during initial injury, repair, and longitudinal growth. Serial
measurements of the proteomic and metabolomic signature will validate novel candidate biomarkers of key
chronic morbidities and identify previously unexplored interactions among diverse molecular pathways in a
systems biology approach to understanding this complex pathophysiology.
Specific Aim 1 (New Science under the K24): Utilize proximity extension assay technology to perform
longitudinal measurement of the circulating proteome in the convalescent period after neonatal CHD surgery
and determine the proteomic phenotype/changes in targeted protein biomarkers preceding two critical
postoperative morbidities: subacute intestinal injury and chronic neurodevelopmental delay.
Specific Aim 2 (Career Development): Expand my skills in the analysis of omics and deep clinical data through
a combination of experiential and didactic training, with an emphasis on learning novel strategies to integrate
and analyze multiple streams of high dimensional data.
Specific Aim 3 (Mentoring): Using our established cohorts as a training platform, develop a pipeline of new
patient-oriented physician-scientists interested in learning and applying data science methods towards
mechanistic, diagnostic, and therapeutic discovery in children with CHD.

Public health relevance
PROJECT NARRATIVE Babies born with complex heart defects often experience a lifetime of surgeries and hospitalizations accompanied by both short and long-term injury to their vital organs (including their brain, heart, kidneys, and intestines). In this project, we will use new laboratory tests capable of measuring hundreds of proteins and metabolites from a tiny blood sample to explore how our children’s bodies respond to their heart surgery and subsequent vital organ injury. We will also use the millions of data points collected to train a new generation of young scientists to improve outcomes for children with complex heart defects using data science techniques.